Regulatory mechanisms of hematopoietic stem cell functions post-transplant

Abstract
Hematopoietic stem cells (HSC) sustain the production of all blood and immune cells throughout life by
differentiating into all blood lineages and regenerate long-lived HSC, ie self-renew. However, although HSC
have high regenerative potential, the actual capacity of ‘self-renewal’, ie regenerating a daughter cell that has
identical properties’ is limited. HSC sustain injury after bone marrow transplantation and become less functional.
A clear understanding of the mechanism responsible for HSC functional decline with HSC transplantation is still
lacking. This lack of knowledge has hampered our ability to maintain HSC functions through divisions and
improve HSCT outcomes. The overall goal of this grant application is to understand the mechanisms behind
HSC functional decline after bone marrow transplantation. We have discovered that once HSCs get activated,
mitochondria irreversibly remodel and do not return to homeostatic conditions. HSCs accumulate dysfunctional
mitochondria due to a progressive decline in mitochondrial quality control mechanisms, including reduced
mitochondrial dynamism such that HSCs carry mitochondria have that are different in shape and functions.
Mechanistically, HSC lose mitochondrial fission activity [ie, loss of the fission regulator Drp1 activity], which
causes a decrease in HSC regenerative potential. In addition, we found that HSC with high repopulation activity
in vivo have high levels of mitophagy. In contrast mitophagy is drastically reduced in HSC after transplantation.
We hypothesize that mitochondrial defects drive HSC functional decline after transplantation. The main
objectives of this project are to understand why abnormal mitochondria in HSC are not removed after bone
marrow transplantation and the impact it has on HSC functions (Aim1). Aim2 will investigate the impact of
abnormal mitochondria on HSC metabolism with a focus the mitochondrial retrograde signaling ATF4-on
carbon/folate pathway. We will test effect of metabolite supplementation in ameliorating HSC functions in vivo
during bone marrow transplantation, using both murine bone marrow transplantation and xenotransplant model
of human CD34+ into immunodeficient recipients. The proposed studies provide a unique opportunity to
examine the specific contribution of abnormal mitochondrial functions to HSC functional decline during and after
bone marrow transplantation. It will investigate the novel concept that HSCs accumulate dysfunctional
mitochondria that reprogram their metabolism driving their functional decline, which may lead to the
identification of novel approaches for pharmacological intervention to maintain HSC functions through divisions.

Public health relevance
The regulation of hematopoietic stem cells (HSC) during bone marrow regeneration are poorly understood. The functional decline of HSC after bone marrow transplantation is thought to be a degenerative process caused by accumulated damage that leads to cellular dysfunction, tissue failure, and death. Evidence has now proven that there is a measurable changes in HSC metabolism after bone marrow transplantation that drive HSC functional decline. The studies proposed in this application will provide information on cellular factors that become deregulated in hematopoietic stem cells after bone marrow transplantation and cause functional decline of the hematopoietic tissue, and will identify conditions under which HSC can be maintained with full regenerative potential. This could be a first step towards designing treatments to improve HSC function during bone marrow regeneration to improve bone marrow transplant outcomes.